Oligodendrocyte extracellular vesicles: a novel therapy for CNS autoimmunity

SUMMARY: Oligodendrocyte extracellular vesicles: a novel therapy for CNS autoimmunity.
Current therapies for multiple sclerosis (MS) target the immune system in an antigen (Ag)-nonspecific manner,
with potentialy serious side effects due to systemic immunosuppression. A longstanding goal in MS research is
to devise an Ag-specific therapy that would suppress only harmful immune responses, while leaving the rest of
the immune system intact. The prerequisite for Ag-specific therapy is identification of the target Ag. MS
pathogenesis is widely believed to be driven by autoimmunity against myelin Ags. However, the relevant Ag(s)
in MS remains speculative, with the possibility that these Ags differ among patients, and over time in the same
patient. Numerous approaches for Ag-specific suppression of autoimmune neuroinflammation have been proven
in experimental autoimmune encephalomyelitis (EAE), an animal model of MS. These approaches rely on re-
establishing peripheral tolerance for self-Ag by delivering the same self-Ag in a non-inflammatory context (eg. in
PBS) via various routes, such as intravenous (i.v.), oral, or nasal. However, translation of these experimental
strategies into MS therapy has been hampered by uncertainty about the relevant Ags in MS patients. In
addressing this issue, we reasoned that if for tolerance induction we used oligodendrocyte (Ol)-derived
extracellular vesicles (Ol-EVs), which naturally contain most or all of the myelin Ags, it would be unnecessary to
identify the relevant myelin Ag(s) in each patient. Further, we also posited that i.v. injection of Ol-EVs will
suppress EAE, similar to well-documented i.v. tolerance induction by free self-peptide. Indeed, our data show
that Ol-EVs contained all the relevant myelin Ags and upon i.v. injection ameliorated ongoing EAE in an Ag-
dependent manner, suggesting that Ol-EVs can be a universal therapeutic agent for MS. Based on these and
additional preliminary data, we hypothesize that human and mouse Ol-EVs contain all relevant myelin Ags, and
upon i.v. administration will ameliorate EAE induced by various myelin Ags. We additionally hypothesize that this
effect is Ag-dependent and mediated by the IFN-/IL-27/PD-L1 axis. This hypothesis will be tested in the following
specific aims: Aim 1. To determine the therapeutic efficacy of Ol-EVs in several EAE models. Since the
significance of this project is to study Ol-EVs as a potential therapy for MS, and we do not know the relevant
Ag(s) in MS, we will test the hypothesis that OL-EVs/i.v. can suppress EAE induced by any myelin Ag, because
all the relevant Ags are present in OL-EVs. Aim 2. To define the mechanism of EAE suppression by Ol-EVs.
Our preliminary data provide a basis for the hypothesis that Ol-EVs/i.v. induce tolerogenic APCs, which diminish
pathogenic Th cell response and suppress EAE via expression of immunoregulatory molecules. Aim 3. To study
the effects of human Ol-EVs in human myelin Ag-induced EAE, and in humanized mice. We will optimize
production of human Ol-EVs, and test the hypothesis that human Ol-EVs/i.v. have adequate therapeutic efficacy
in EAE models, and in humanized mice to determine if findings in mice are paralleled in this human-like system.

Public health relevance
Narrative Current therapies for multiple sclerosis (MS) suppress the immune system in general, which can cause serious side effects. We propose to study the use of particles (extracellular vesicles) released by cells that produce myelin, which is damaged by the immune system in MS. Our findings in MS-like disease in mice show that these particles suppress immunity against myelin, without general suppression of the immune system, which would be advantageous over current therapies for MS.